Supplement to Support the Development of a New Multiplexed Imaging Tool using Raman Spectroscopy for Breast Cancer

Project Summary
Breast cancer, in particular, is very heterogeneous with many morphological and molecular features that present
differently across patients. Failure to fully understand the molecular expression and tumor heterogeneity across a
patient's tumor can lead to administration of ineffective therapies that increase patient morbidity and healthcare
costs. The -omics era has made it possible to identify several new molecular markers involved in breast cancer
development, survival, invasion and even predicting treatment response. We currently lack an easy way to obtain
high content molecular information while providing high resolution spatial profiling across a patient's tumor. This
proposal aims to provide physicians with an entirely new multiplexed molecular imaging strategy that has the potential
to offer both high content molecular expression and spatial profiling in a single histology image. Raman
spectroscopy in conjunction with surface enhanced Raman scattering (SERS) nanoparticles is an optical imaging
technique that can offer unsurpassed sensitivity (on the order of fM) and multiplexing capabilities to the field of
histology imaging with the potential to provide rich molecular details on the microscopic level. Clinicians will be
able to utilize the imaging strategy on the same tissue sections prepared for histology. Incorporating it into the
pathology workfiow could enable physicians to better understand the patient's tumor type and stratify patients to
receive the most effective therapeutic regimen possible. This unique histology imaging strategy also has the
potential to identify new molecular trends in patient's tissue samples that could be used to predict how aggressive
their tumor is or how well the patient is likely to respond to given therapies. This innovative ex-vivo diagnostic
strategy has a high likelihood for clinical translation; offering rapid whole tissue section imaging for multiple
biomarkers simultaneously. Our approach begins by developing a new set of sensitive SERS nanoparticle (NP)
batches, each designed with a unique spectral barcode to enable simultaneous molecular interrogation of an entire
tissue sample within a single image. After fabrication and characterization of our newly developed multiplexed SERS
nano particles, we will test their multiplexed imaging capabilities and tumor targeting efficiency in various breast cancer
models including cell culture and on de-identified tissue sections. Our nanoparticles will actively target multiple breast
cancer receptors through chemically conjugated targeting ligands. We will assess the tumor targeting efficiency of
our newly developed nanoparticles with microscopic Raman imaging tools and compare with gold standard
immunohistochemistry {IHC) staining. These results will be an important step in the clinical translation of this new
multiplexed Raman imaging approach; to provide rapid spatial molecular profiling of a given tumor while enabling
a more effective personalized therapy to the patient.

Public health relevance
Public Health Relevancy Statement The proposed research is intended to provide physicians with an entirely new imaging tool that has the potential to offer important molecular information about an individual patient’s tumor in a single image. Clinicians will be able to utilize the new multiplexed imaging strategy on the same tissue sections prepared for histology. Incorporating it into the pathology workflow could enable physicians to better understand the patient’s tumor type and stratify patients to receive the most effective therapeutic regimen possible.